Support of NCIP activities

This funding is in support of various caBIG(R) activities including such as: caBIG TPM, IOB Quality Assurance, IOB Apps Engineering, IOB Core Engineering, CAGRID PORTAL, IOB CABIG VCDE, Community Alliance and Consultant-International Outreach